IP21-002 Enhanced Surveillance for New Vaccine Preventable Diseases

PROJECT SUMMARY - Mandatory Component A
Acute respiratory illness (ARI) and acute gastroenteritis (AGE) are the leading causes of death worldwide in
young children. Established leading viral etiologies of AGE are rotavirus and norovirus and respiratory syncytial
virus (RSV) and influenza virus for ARI. Our understanding of ARI and AGE epidemiology is constantly
changing due to spatiotemporal fluctuations, discovery of new or re-emerging pathogens [e.g. enterovirus D68
(EV-D68) and severe acute respiratory syndrome coronavirus 2 (SARS-CoV-2)], and use of rotavirus and
influenza vaccines. Hence, surveillance efforts are imperative to define ARI and AGE disease burden,
causative pathogens, outcomes, and vaccine impact. The primary influenza prevention strategy in the United
States is vaccination for all individuals six months or older. There is a paucity of data regarding vaccine
effectiveness (VE) against laboratory-confirmed influenza in children, and influenza viruses and vaccine
antigenic components change annually. Therefore, perpetual assessments of VE are needed to monitor the
impact of influenza vaccination on disease and inform strategies to improve magnitude, durability, and breadth
of protection. Pediatric SARS-CoV-2 vaccines are an urgent public-health priority and likely will become
available on an accelerated timeline in an effort to curb the COVID-19 pandemic. Rigorous, prospective
surveillance of SARS-CoV-2 VE is crucial to support reliance on vaccines as primary prevention. Thus, the
first main objective of this project is to conduct population-based active surveillance for respiratory and
enteric viral pathogens in pediatric inpatient and emergency department settings and asymptomatic
controls. Our team of Vanderbilt investigators is highly experienced in conducting prospective, population-
based ARI and AGE surveillance. We propose to conduct ARI and AGE surveillance with the following specific
aims: 1) To perform prospective, active surveillance to determine the etiology and burden of inpatient and
emergency department (ED) acute viral respiratory and enteric diseases among the pediatric population. 2) To
characterize the clinical and epidemiologic factors of pediatric infections (including in asymptomatic children)
through active surveillance. 3) To evaluate vaccine effectiveness and impact of vaccines and other
interventions (e.g., immunoprophylaxis with antiviral agents or other therapeutics) available or projected to
become available during the period of performance. The second main objective of this project is to conduct
surveillance and epidemiologic characterization of acute flaccid myelitis syndrome in children. Given
the epidemiologic connection between EV-D68 infection and acute flaccid myelitis (AFM), it will be important to
conduct rigorous, active, longitudinal surveillance for AFM across multiple consecutive seasons; carefully
define AFM clinical spectrum, risk factors, incidence rates, and laboratory parameters; and document local
circulation of EV-D68 and other ARI and AGE pathogens coincident with increased AFM occurrence. This work
underpins development of preventive, diagnostic, and therapeutic strategies for AFM.

Public health relevance
PROJECT NARRATIVE – Mandatory Component A Continuing our established surveillance systems for pediatric acute respiratory illness (ARI) and acute gastroenteritis (AGE) within the New Vaccine Surveillance Network at Monroe Carell Jr Children's Hospital at Vanderbilt, we will determine population-based rates of viral ARI due to common etiologies (e.g., RSV, influenza, metapneumovirus, rhinovirus, adenovirus, parainfluenza viruses, and coronaviruses [including severe acute respiratory syndrome coronavirus 2 ( SARS-CoV-2)] and viral AGE due to common etiologies (e.g., rotavirus and norovirus) among children residing in Davidson County, TN. We will enroll children <18 years from inpatient and emergency department settings who present with fever and/or respiratory symptoms (ARI) or who have a history of vomiting or diarrhea (AGE) and collect nose/throat or stool specimens, respectively. We will identify individuals with acute flaccid myelitis (AFM) and define epidemiologic features, clinical characteristics, and risk factors of AFM in the surveillance area.